High-Throughput in Vivo Discovery of Novel Countermeasures Against Organophosphate-Induced Seizure and Status Epilepticus Using Zebrafish

PROJECT SUMMARY
Chemical threats are a major public health concern and CounterACT recognizes the need to identify new
medical countermeasures (MCMs) that improve the public health response to mass casualty events related to
chemical threats. Organophosphate (OP) agents are of particular concern due to their wide availability in
common pesticides and their use in chemical nerve agents. OP-induced seizures are a serious consequence
of OP-intoxication and best agents for treating this complication are unclear. Major gaps include limited
opportunities for systematic clinical evaluations in humans prior to mass casualty, drawbacks to existing
medication, which may not control seizures or excitotoxicity, and worsen sedation; and lack of direction in
discovering new MCMs. To address these gaps, we propose to characterize a zebrafish model of OP-induced
seizures and excitotoxicity using chlorpyrifos-oxon (CPO)1 – an active metabolite of the common OP pesticide,
chlorpyrifos -- and to advance its use for high-throughput compound screening to identify novel MCMs against
OP-induced seizures and excitotoxicity. In Aim 1, we will characterize a larval zebrafish model of CPO-induced
seizure and optimize parameters for the identification of novel countermeasures. In Aim 1A, we will confirm
seizure activity using both electrophysiology (EEG) as well as noninvasive measures based on calcium
fluorescence. In addition, we will assess survival and excitotoxicity as evidenced by the burden of apoptotic
cells following seizures using TUNEL assay and less time-intensive acridine orange (AO) assay. In Aim 1B,
we will identify the ideal assay parameters for detecting novel countermeasures to CPO-induced seizures by
identifying the maximum tolerated dose in larval zebrafish of existing countermeasures followed by a CPO
dose-response experiment to identify the conditions that result in 25-50% reduction in CPO-induced seizures
versus control. This target is chosen to allow detection of the effect of existing countermeasures while
providing dynamic range for the detection of superior countermeasures. In Aim 1C, we will quantify sedation
as a function of anti-seizure activity in conventional AEDs, by establishing ED50 for several AEDs in response
to CPO-induced seizures; these data will be compared to the sedative effect of AEDs in the visual startle
response (VSR) and acoustic startle response (ASR) assays. Finally, in Aim 2, we will implement a whole
organism compound screen for novel MCMs against OP-induced seizure and excitotoxicity, and prioritize hits
based on ranked paired robust strictly standardized mean difference (SSMD*) and least sedating effects.
Taken together, this exploratory R21 is responsive to multiple facets of the CounterACT program and provides
a framework for whole organism in vivo discovery of novel countermeasures against CPO that may be
extended to additional OP agents.

Public health relevance
PROJECT NARRATIVE Chemical threats such as organophosphate (OP) agents are a major public health concern. Seizures are a serious consequence of OP-intoxication. We will characterize a zebrafish model of OP-induced seizures using chlorpyrifos-oxon (CPO) and pursue high-throughput screening to identify novel countermeasures.